Novel role of urinary urate in renal cystogenesis and water regulation

PROJECT SUMMARY/ABSTRACT
Autosomal Dominant Polycystic Kidney Disease (ADPKD), a genetic disorder leading to progressive renal cyst
growth, affects 12 million people globally. Arginine vasopressin (AVP) is a key driver of cystogenesis, and in
rodent PKD models, the absence of AVP completely prevents cyst formation. Although V2 receptor (V2R)
antagonists effectively inhibit cyst growth, their use is limited by significant polyuria (>6 Liters/day). An
alternative strategy involves enhancing renal water reabsorption to suppress central AVP release. Promising
approaches include regulating the water channel aquaporin-2 (AQP2) through pathways independent of V2R.
The urate transporters GLUT9b and ABCG2, located in the collecting duct, may play roles in water
homeostasis. Notably, hyperuricosuria is associated with hyponatremia and Glut9 deletion in mice lead to
severe polyuria. Additionally, ABCG2 inhibitors might be associated with improved kidney function in ADPKD.
Our preliminary findings suggest that intracellular urate accumulation promotes aquaporin-2 (AQP2) exocytosis
via AMP-activated protein kinase (AMPK) phosphorylation, independent of V2R/PKA pathways. The
overarching hypothesis posits that elevating intracellular urate in collecting ducts promotes AQP2 exocytosis
and water reabsorption, suppressing central AVP release and reducing renal cystogenesis in ADPKD. Aim 1
investigates the impact and mechanisms by which urate controls AQP2 trafficking, evaluating the impact of
ABCG2 inhibition by Ko143 analog and probenecid on urinary concentration in V2R knockout mice, assessing
the impact of ABCG2 deletion on urinary concentration capacity and AQP2 phosphorylation, and exploring
mechanisms by which increased intracellular urate, due to GLUT9b overexpression and ABCG2 inhibition,
controls AQP2, cyclic AMP levels, Protein Kinase A (PKA), and AMPK activities in V2R-knockdown cell lines.
Aim 2 determines the impact and underlying mechanisms of ABCG2 inhibition and genetic deletion in reducing
renal cyst growth and mitigating tolvaptan-induced aquaresis in ADPKD, assessing the impact of ABCG2
inhibition and deletion on PKD amelioration in Pkd1RC/RC mice, investigating the long-term impact of ABCG2
inhibition and genetic deletion on the anti-cystogenic and aquaretic effects of tolvaptan, and exploring effects of
elevated intracellular urate, ABCG2 inhibition, and AMPK inhibitor on in vitro cystogenesis, cAMP levels, PKA,
AMPK, and PDE activities in WT and Pkd1 mice and human collecting duct cells. These investigations aim to
elucidate the novel interplay between intracellular urate and AQP2-mediated water transport regulation in
ADPKD, potentially leading to innovative treatments to slow cystogenesis.

Public health relevance
PROJECT NARRATIVE This research targets Autosomal Dominant Polycystic Kidney Disease (ADPKD), a prevalent genetic disorder and the fourth leading cause of kidney failure. We aim to develop new therapies by investigating how urate transporters GLUT9 and ABCG2 influence intracellular urate and water transport regulation in the renal collecting ducts, potentially inhibiting cyst growth by suppressing vasopressin (AVP) release. This novel approach may also mitigate the polyuria induced by tolvaptan, thereby improving the tolerability of the only approved treatment for ADPKD.